Mitigation of multi-organ delayed effects of acute radiation exposure (DEARE) with ACE2 agonist diminazene aceturate.

SUMMARY
With the advent of hematopoietic growth factors for mitigation of acute radiation syndrome (ARS), victims of
nuclear or radiological events will be more likely to survive ARS but also at greater risk for the development of a
range of late multi-organ toxicities collectively referred to as the delayed effects of acute radiation exposure
(DEARE). To date, there are no FDA-approved medical countermeasures (MCMs) for the treatment of DEARE.
This application to RFA-AI-23-059 (Development of Candidate Radiation/Nuclear MCMs) proposes to address
this unmet need and will focus on the unmet need for MCMs against two life-threatening subsyndromes of
DEARE: radiation pneumonitis and nephropathy. Here, we propose to screen three candidate MCMs which
target the non-canonical, alternative renin angiotensin system (RAS).
As a counterbalance to the canonical RAS, the alternative RAS has broad tissue-protective function by promoting
vasodilation, reducing inflammation, and reducing fibrosis. For these reasons, several recent and ongoing clinical
trials are evaluating alternative RAS activators for the treatment of severe COVID-19. Data from our lab and
others also supports the potential for alternative RAS activation in the treatment of radiation toxicities. Our
laboratory has shown diminazene aceturate (DIZE) a small molecule agonist of the alternative RAS pathway
promotes survival in rat models of ARS and DEARE. Important to this application, DIZE treatment also mitigated
injury to the lung and kidney as evidenced by improved survival during the sub-syndromes of lung and kidney
DEARE. Based on these data, we hypothesize the alternative RAS pathway can be targeted pharmacologically
to mitigate radiation-induced multi-organ DEARE.
Here, we propose a stepwise approach to targeting three key players in the alternative RAS pathway:
angiotensin converting enzyme 2 (ACE2), Ang(1-7), and the Mas receptor (MasR). Each Aim of this application
will target one of these players using the following lead candidate therapies: DIZE (ACE2 activator), TXA127
(synthetic Ang(1-7)), and BIO101 (MasR activator). We will evaluate the efficacy of the candidate MCMs in an
established rat DEARE model which recapitulates the anticipated human sequelae of acute and delayed
toxicities. For each candidate MCM, the primary outcome measure will be mitigation of all-cause mortality, which
is the clinically relevant endpoint for FDA approval under the Animal Rule.

Public health relevance
Project Narrative This application to RFA-AI-23-059 Development of Candidate Radiation/Nuclear Medical Countermeasures (MCMs) will evaluate if therapeutics targeting the alternative renin angiotensin system (RAS) mitigate multi-organ radiation injury. This study will address the unmet need for MCMs against multi-organ DEARE and the life- threatening sequalae of lung and kidney DEARE. The three Aims will screen candidate MCM targeting three key players in the alternative RAS pathway: ACE2 (Aim 1), Ang(1-7) (Aim 2), and MasR (Aim 3).